Selection of oncogenic Ras mutations through tumor promotion mechanisms

Project Summary
Recent investigations have revealed that oncogenic mutations are not sufficient for initial stages of tumorigenesis
and that the microenvironment plays a significant role in promoting neoplastic growth of a tumor. This
microenvironment surrounding a mutated cell can be influenced by many promotion processes, including
environmental exposures, tissue damage, and chronic inflammation. This proposal aims to investigate the
mechanisms by which promotion, or non-mutagenic processes, can influence the selection of mutant clones
which eventually populate a tumor. This project will rely on theories from cancer genetics, tumor promotion, and
evolutionary cancer biology in order to provide insight into the coordination between promotion and oncogenic
mutations present in a cell. Through the use of a well-established model of chemical carcinogenesis, this project
will address a fundamental question regarding the molecular consequences of tumor promotion. This
carcinogenic regimen can produce both Hras mutant tumors and Kras mutant tumors, merely by adjusting the
genetic background of the mouse. This provides the ideal tool for us to ask the question, what are the different
promotion mechanisms which select for tumors with different mutations? To address this question, the proposed
project aims to characterize promotion mechanisms on the backgrounds of the mice which are known to produce
tumors with different mutations. The first aim will investigate how macrophage infiltration during promotion
coordinates with oncogenic Hras signaling. This will be addressed by computationally identifying signaling axes
between macrophages and epithelial cells from skin collected at different time points after application of a
promoter. The second aim will define the active functional modules in the Kras-tumor-permissive skin, in
response to a promoter. This will be achieved by constructing gene co-expression networks from single cell RNA
sequencing of skin collected subsequent to promoter treatment in the skin. The proposed research will be
completed by a graduate student with significant experience in both cancer biology and computational biology.
It will be supervised by and conducted in the lab of Allan Balmain, an expert in the field of skin cancer genetics
and tumor promotion. This training plan takes advantage of the highly collaborative and innovative research
environment in the Helen Diller Family Comprehensive Cancer Center, which facilitates access to renowned
scientific mentors and guidance in the proposed work. At the University of California, San Francisco (UCSF), the
graduate program in Biomedical Sciences is regarded as one of the best due to its inclusion of professional
development and training resources offered, which will support this highly motivated student to develop an
independent research career. Completion of the proposed work will thus expand knowledge on a critical question
in cancer biology and is enabled by an excellent institutional environment. Understanding how oncogenic
mutations can coordinate with tumor promotion mechanisms in the mutant cell’s microenvironment will provide
novel insights towards early detection and prevention strategies for cancer.

Public health relevance
Project Narrative Healthy cells with mutations associated to tumor growth do not all become tumors. In the proposed research, the mechanisms connecting oncogenic Ras to microenvironmental selection pressures which promote neoplastic growth will be identified. Understanding promotion, or non-mutagenic, processes that are involved in the evolutionary selection of mutant cells to become tumorigenic will inform novel strategies for early detection and therapeutic prevention of deadly Ras-dependent cancers.